Acquisition of Individually Ventilated Cage Rack Systems for the University of Mississippi Vivarium

Project Summary
Utilization of individually-ventilated cage systems (IVCs) for housing rodents has become the
industry standard across the fields of biomedical research. The combined approach of socially
housing rodents in filter-topped, microisolator cages with tightly-controlled air exchange rates
and continuous monitoring of the homecage microenvironment promotes animal welfare,
occupational safety, and research reproducibility. Ultimately, IVCs reduce animal husbandry
burdens thereby encouraging efficient resource utilization and time allocation. At the University
of Mississippi (UM), increased faculty recruitment and the recent growth of multiple animal
research laboratories has resulted in a rising momentum to modernize our shared use animal
facilities. Recent surveys of rodent research teams on campus revealed a robust demand for
the incorporation of IVCs throughout the rodent vivarium facility. The goal of this proposal is
to help meet the needs of animal research teams by implementing IVCs throughout the
rodent housing rooms in our shared-use vivarium. The Vice Chancellor for Research, Office
of Research Integrity and Compliance, and the Institutional Animal Care and Use Committee at
UM gathered feedback from investigators, animal care staff, external consultants, and our
accrediting bodies to assess areas for improvement and modernization throughout all animal
housing areas on campus. Administrative units within the School of Pharmacy and Office of
Research and Sponsored Programs recently supported the acquisition of 3 RAIR HD Super
Mouse 750™ IVCs from LabProducts. The implementation of these systems was
straightforward and subsequent benefits in microenvironment control and signs of animal and
researcher satisfaction are clear. We now propose to implement the RAIR HD Super Mouse and
Super Rat systems throughout all rodent housing rooms. Our facility is fully-equipped for
immediate implementation, with no renovations required. The call for modernization is further
driven by standing infrastructure concerns relating to the HVAC and potential allergen
exposures within our facility, which the animal oversight teams responding to swiftly and
strategically. Acquisition of the RAIR HD Super systems is a component of our strategic actions,
as they have additional innovative air flow filtration technologies that can improve HVAC burden
and allergen exposure. Thus, incorporation of IVCs in our rodent housing facility will allow us to
remediate standing infrastructure concerns, prevent multiple potential issues, and promote
efficiency within our animal research program.

Public health relevance
Project Narrative Housing rodents in individually ventilated cage systems promotes the health and welfare of both animals and animal researchers while simultaneously improving research reproducibility and resource utilization. By incorporating modernized, safe, and efficient ventilated cage systems throughout our shared-use rodent housing facility, the University of Mississippi will aide in overcoming deficiencies in the facility infrastructure, enhance stability of the rodent housing microenvironment, reduce pathogen and allergen spread, lower the frequency of animal handling, and address concerns and needs of our animal research teams.